International Research Conference In Neurodegenerative Diseases 2025

Summary
Neurodegenerative diseases (NDs) are expected to double in the next two decades. This will result in an
extraordinary global burden on healthcare budgets and families. Most neurodegenerative diseases are idiopathic
and thought to arise from multi-factorial insults, many modifiable, rather than a single cause. Even in largely
genetic-based NDs, their emergence and severity are influenced by modifiable factors, most of which are
common across NDs. A major barrier preventing effective therapy development, or concrete public heath
prevention-based directives is the lack of efficient integration of research findings across these multiple complex
factors. In fact, the current biomedical research model, naturally siloed to deliver knowledge depth at the expense
of integration, sometimes hinders the broader multi-disciplinary study of complex syndromic diseases including
neurodegenerative diseases. To address this gap, we propose to expand the current format of an existing annual
conference, the International Research Conference in Neurodegenerative Diseases to now include
programmatic aspects that foster interdisciplinary exchange of ideas and the active participation of non-
neurodegeneration investigators studying risk-associated aspects of relevance to neurodegenerative disease.
This unique opportunity can be achieved by immersing the existing IRCND meeting into the University of Florida
College of Medicine environment with nationally and internationally renowned research centers and institutes in
neurodegeneration (CTRND, Center for Neurogenetics, & Fixel Institute) and, more importantly, leading centers
spearheading research into physiological systems and mechanisms linked to neurodegenerative diseases.
These include but are not limited to aging (UF center for cognitive aging & translational research), sensory loss
(Center for Smell & taste), respiratory control (Breathe Center), and environmental/occupational risk factors such
as infection (Sepsis Research Center) and traumatic brain injury (BRAIN center). Additionally, supported by a
$70m investment from NVIDIA, UF provides a unique opportunity to harness the rapidly growing artificial
Intelligence (AI)-focused biomedical research infrastructure to further foster knowledge expansion and
collaborations that can lead to a better integration of these complex multifactorial traits and neurodegenerative
disease mechanisms. The goal is to help “de-silo” neurodegenerative disease research by spurring
interdisciplinary collaborative efforts that will nourish science, create “integrative” neurodegeneration new
scientists, and more effectively drive new therapy development.

Public health relevance
Narrative The complex etiology and heterogeneity of neurodegenerative diseases makes the development of prediction tools and treatments particularly challenging. Multidisciplinary research that incorporates neurodegeneration mechanisms, a mechanistic understanding of the risk factors, and knowledge of approaches that facilitate the integration of these aspects are needed but are lacking because of the siloed nature of biomedical research. The focus of the IRCND 2025 meeting is to create a unique scientific forum where researchers from disciplines that would not typically interact to gain new knowledge, exchange ideas, begin collaborations, and that will foster the scientific development of new integrative neurodegeneration scientists.